Assessing feasibility of gastric cancer screening in the US

ABSTRACT
In the United States, gastric cancer (GC) is commonly diagnosed at an advanced stage with a poor
overall 5-year survival of 31%. Disparities in GC incidence and mortality affect every minority group, exceeding
those seen in lung, breast, and colon cancer. GC incidence is also rising in younger patients, with a 10%
increase over the past decade. Thus, there is an urgent and unmet need for an effective strategy to detect GC
early to improve clinical outcomes of patients with this disease.
GC incidence is equivalent to that of cervical cancer (7 per 100,000) and approximately 25% that of
colorectal cancer, cancers for which screening is established. Early detection affects survival; 5-year survival is
95-99% in localized GCs as compared with 7% in metastatic GC. Given the relatively lower prevalence in the
general population, a novel targeted approach of screening asymptomatic high-risk individuals, rather than
universal screening, would be required to form the basis for a GC screening program in the US.
Known risk factors for GC include sex, age, race, ethnicity, family history, smoking, and H. pylori
infection, variables easily available in the electronic health record (EHR). To date, risk models to predict GC
risk have mainly been studied in Asia, demonstrate limited accuracy, and are not generalizable to the US
population. Machine learning (ML) methods have been explored in cancer prediction modeling. No studies
have applied an EHR-based ML model to an average risk population to identify high-risk individuals
appropriate for GC screening.
A future RCT assessing the effectiveness of GC screening in a high-risk GC population would require
robust preliminary data. Mathematical modeling is commonly used to support clinical decision-making that can
simultaneously consider the impact of varied factors (e.g., patient characteristics, adverse events, cost) on the
risk/benefit ratio of treatment. The overall goal of this study is to establish the feasibility of GC screening in
diverse high-risk US populations. The Specific Aims are to: 1) Develop and validate a predictive model based
on structured and unstructured EHR data that accurately identifies individuals at high risk for GC; and 2)
Develop a mathematical model of the natural history, diagnosis, treatment and outcomes of GC and project the
potential benefits, harms, and cost-effectiveness of GC screening in high-risk individuals.
To achieve these Aims, we will refine our preliminary EHR-based ML model using approximately 5
million patient records from diverse populations at the Cleveland Clinic and Columbia University. We will
externally validate the prediction model using an independent sample of ~3 million patients from University of
California at San Diego, CA. We will then develop a mathematical model to determine the optimal use of GC
screening by evaluating benefits versus harms and cost-effectiveness. Results from these studies will address
a major unmet health need and improve survival in a preventable and curable cancer in at-risk populations.

Public health relevance
PROJECT NARRATIVE Gastric cancer (GC) is diagnosed at an advanced stage and associated with poor survival, especially in minority populations. Using data from the electronic health record from Cleveland Clinic, Columbia University, and University of California at San Diego, we will develop and validate a machine learning risk prediction model that can identify high-risk individuals appropriate for GC screening. We will then develop a simulation model to assess the effectiveness and the cost-effectiveness of GC screening in high-risk individuals, thereby providing data needed to form the basis for a novel GC screening program in the US.